Home-based digital exercise training program to improve physical function of older sepsis survivors – HEAL Sepsis Trial

ABSTRACT
Sepsis, an exaggerated response to infection, affects all ages, but it is more prevalent in older adults. Older
sepsis survivors are commonly discharged to long-term acute care facilities, where they often die within 1 year.
We believe that those who return home from the hospital lose the momentum of physical function improvement
after early in-hospital rehabilitation and often face exacerbation of comorbidities and decline in physical function.
Based on our longitudinal observational data, older sepsis survivors have poor health status and physical
function lasting at least 1 year after sepsis, and in contrast with younger survivors, older patients do not regain
their function. Our aging research suggests that physical activity interventions prevent mobility disability in rather
healthy older adults, but older sepsis survivors will be profoundly frailer, more sedentary, lower-
functioning and will unlikely be capable of traveling to participate in supervised exercise training
programs in our research facilities. Currently, we are unaware of any home-based therapeutic
approaches to improve physical function of older sepsis survivors. Current mobile health applications can
deliver structured home-based exercise programs to reach daily activity goals. For example, the Blue Marble
Health Platform (BMHP), developed and validated with the support of NIH contains over 100 avatar-guided
strengthening, balance, and aerobic exercises, along with 23 standardized assessments and a personal health
diary. This digital and remotely monitored exercise training program might be promising for sepsis survivors with
poor health status, who are unlikely to be able to travel to participate in exercise interventions. Our proposed
study will test the safety, feasibility and efficacy of a novel 12-week physical activity intervention to improve
physical function in older sepsis survivors utilizing an app-based digital exercise training platform. We propose
to randomize 40 sepsis survivors (aged >65 years) with an SPPB score <6 at the time of their discharge to home
from the hospital into the intervention or a standard care control group. Both groups will receive a tablet with the
BMHP app, which contains all of the physical function assessments, and a health diary. The intervention group
will also receive personalized avatar-guided exercises as well as text message reminders to exercise for 30min
each day, 5 days/week. For the control group, participants will record their daily activities using the BMHP health
diary. A research coordinator will call all participants weekly to ask questions about their health status and remind
them to charge the tablets. At baseline and 12-week follow-up, participants will use the app to complete the app-
guided physical function assessments and we will measure activity levels using hip-worn accelerometers. This
project will be the first to test the safety, feasibility and efficacy of a digital physical activity intervention in this
high-risk population of older sepsis survivors. The results will provide critical information regarding the feasibility,
tolerability, and efficacy of this novel approach to enhance these patients’ physical function.

Public health relevance
PROJECT NARRATIVE Older adults are affected by sepsis more often than younger patients and, even more worrisome, have a higher risk of physical disability and death within 1 year after sepsis. While these older sepsis survivors need therapeutic approaches to improve their physical function after returning to home to continue their momentum of physical function improvement initiated by early physical/occupational therapy in hospital, supervised exercise training programs might not be feasible due to the patients’ poor health status and limited access to physical therapy/fitness facilities. To address this issue, our proposed study will test a novel and practical home-based, digitally delivered physical activity intervention that does not require visits to intervention sites and is tailored to each participant’s functional status and progress.